Neural mechanisms for decoding olfactory information in Drosophila

Neural encoding, the process by which the brain converts sensory stimuli into patterns of electrical activity within neurons, is critical for sensation to guide action. Despite this importance, little is known about how
neural codes are actually used – or “decoded” – by downstream networks in the brain. This gap is due to two
basic challenges: (1) causally perturbing the code with spatiotemporal precision, and (2) measuring the resulting activity from identified postsynaptic target neurons.
Here, we propose to overcome these challenges, by investigating how an olfactory neural code is decoded by its downstream network in a tractable experimental system: the fruit fly, Drosophila. We have developed new methods to “write” spike patterns into populations of central projection neurons with single cell-type
resolution using 2-photon optogenetics, while recording from their postsynaptic target neurons, which we have
recently identified. This enables direct causal control of precise spiking features of the olfactory neural population code. In Aim 1, we will control combinatorial patterns of spike rates and relative spike latencies in projection neurons with 2-photon optogenetics to determine how these patterns are decoded by downstream neurons. In Aim 2, we will combine 2-photon optogenetic stimulation with olfactory stimulation to examine how
sensory adaptation changes the logic of decoding. In Aim 3, we will test how the downstream neurons are
themselves flexibly decoded into hunger-dependent chemotaxis behavior. Together, these studies will reveal
basic mechanisms by which the brain decodes its own neural code for olfaction.
Although there are differences between flies and mammals, the basic logic of neural coding is remarkably conserved between invertebrates and vertebrates. These similarities suggest that discoveries made in the
fruit fly will be relevant to the mechanisms of decoding in other animals. A more thorough understanding of the
principles of neural decoding within the brain has the potential to transform the development of novel brain-
machine interfaces that could improve the outcomes of patients with brain injuries.

Public health relevance
Despite its importance to normal brain function, neural decoding is much more poorly understood than the process of neural encoding. This proposal applies innovative methods to develop fundamental new knowledge about the circuit, cellular, and synaptic mechanisms of neural decoding. An improved understanding of how the brain processes its own sensory code could help guide the development of improved therapies for rehabilitation after brain injury.